A data resource for high resolutionneuropathological and omics analysisof Alzheimer's disease

ABSTRACT (DATA CORE)
The Allen Institute has demonstrated a tradition of excellence by creating data frameworks to support the
dissemination of biological data and analysis tools for the research community. The Allen Brain Atlas data portal
(http://www.brain-map.org) is a comprehensive data navigation platform, containing gene expression, brain
connectivity, reference atlases and characterization of in vitro and in vivo neuronal cells from multiple species,
including human, mouse and non-human primate. The AD Data Core will build on this foundation, to provide
centralized data integration and presentation solutions for large-scale data sets derived from the AD Center
consortium. The AD Data Core will also form partnerships with other centers and user groups, to maximize
impact of the rich data being generated through the AD cell characterization projects.
New tools for detailed molecular and spatial analysis of single cells are revolutionizing our understanding
of the brain, but the power of emerging techniques has not yet been applied to characterize neuropathology in
Alzheimer’s disease (AD). This proposal aims to address this gap by using transcriptomic, epigenetic and
multiplex molecular spatial analysis methods to characterize AD pathology at the level of cell types. A centralized
and managed approach to collecting, storing, processing, annotating, analyzing and sharing the data is essential.
Successful integration will yield a foundational data set depicting a molecular profile of AD, and the AD Data
Core will serve results to the community via a catalytic open web portal. The AD Data Core will also leverage
methods being developed by major single cell profiling initiatives, to benefit AD research. The Allen Institute for
Brain Science, NIH BRAIN Initiative Cell Census Network (BICCN) and the Human Cell Atlas (HCA) have funded
complementary efforts to characterize nonpathological brain at the cellular level, including a Brain Cell Data
Center (BCDC), which the AD Data Center proposal is designed to synergize with. The expertise and
methodological tools required to build the BCDC have been developed by many members of the team proposed
for the AD Data Core. Utilization of an existing, rigorous collaborative effort offers great economy to the process
of building out an “arm” of cellular profiling capability for AD. Best practices that have been developed for
maximizing data usability can now be brought to AD research with this project. Synergy with these cell profiling
initiatives offers opportunity to accelerate AD research progress by leveraging content from other cell-centirc
databases and corresponding analysis methods. The proposed AD Data Core will also be an end-to-end
platform that can accommodate future scale, such as growth of patient cohorts, new data modalities, and
additional clinical dimensions of AD or related cognitive disorders. Finally, the AD Core will engage with clinical
and research communities through accessible web-based tools for data navigation, and dissemination of
information through outreach approaches such as forums, hackathons and informational narratives.

Public health relevance
PROJECT NARRATIVE (DATA CORE) The AD Center will create and manage large-scale datasets of different experimental modalities, originating from member institutions using centralized data infrastructure to facilitate data storage, processing and analysis via a community-accessible data portal. There is an increasing need to enhance data interoperability and harmonization among researchers to allow meaningful data analysis and simplified data accessibility for reuse; hence, one of the objectives of the AD Data Core will be to enable cross-modality search, analysis and visualization of cell type-specific information from related datasets. We will build new infrastructure to support the novel tissue and experimental workflows being generated by AD Center projects, and customize software management systems to manage and store data and metadata, to produce an integrated data service platform for maximum research community impact.